Screen Smart: Using Digital Health to Improve HIV Screening and Prevention for Adolescents in the Emergency Department

Project Summary:
Adolescents and young adults (AYA) are disproportionately affected by HIV in the US. Despite adolescents
accounting for over 20% of new infections, this age group is the least likely to be tested for HIV, linked to care,
and achieve viral suppression when compared to their adult counterparts. Further, AYA also have low rates of
HIV awareness and initiation of HIV Pre-Exposure Prophylaxis (PrEP). Therefore, there is an urgent need to
expand HIV screening and prevention strategies to nontraditional healthcare settings such as emergency
departments (ED) to reach those adolescents who would otherwise not receive preventive healthcare. The goal
of this application is to leverage our recent insights obtained from a multi-center, ED-based, adolescent
gonorrhea and chlamydia screening study and apply them across a national pediatric ED research network by (1)
adapting, refining, and testing this process to increase universally offered, opt-out HIV screening among
adolescents in the pediatric ED and (2) link at-risk adolescents to PrEP services and preventive care. This will be
accomplished through a network of children’s hospital EDs with a track record of robust research collaboration
(Pediatric Emergency Care Applied Research Network or PECARN). This research will contribute to the
evidence base for creating clinically effective and sustainable HIV screening programs that can be successfully
implemented into the clinical workflow of the ED. It will also improve identification and linkage to PrEP care for at
risk adolescents using mHealth strategies by first identifying AYA who are PrEP candidates based on their
responses to a computerized sexual health screen (cSHS) and subsequently (1) providing clinical decision
support to providers via the electronic health record and (2) direct text messaging from the cSHS to PrEP
candidates providing educational content and connecting youth to a PrEP navigator. This intervention will rely on
an innovative approach that electronically integrates patient-reported data to guide clinical decision support. This
work is significant because it has the potential to shift current ED clinical practice paradigms from only acute
health encounters to participation in the broader management of public health and prevention, and it will fill gaps
in the literature needed to provide evidence for the best method of HIV screening in a pediatric ED setting. Using
a previously developed tablet-based, broad scale GC/CT screening process, we will adapt, refine, and test this
process with the aim of increasing universally offered, opt-out HIV screening in the pediatric ED through
electronic integration of patient reported data for provision of clinical decision support for HIV screening and
identification of PrEP candidacy, and then use mHealth to link patients to PrEP services. This research is novel in
that it shifts the usual clinical practice paradigm of HIV screening and prevention in the pediatric ED from a
scattered approach to a consistent and sustainable approach that is critical to addressing the HIV epidemic
among adolescents.

Public health relevance
Project Narrative Adolescents are disproportionately affected by HIV and often access the emergency department (ED) as their only source of care. This multicenter, pragmatic trial seeks to adapt, refine, and test a previously developed tablet-based, broad scale gonorrhea and chlamydia screening intervention process to increase universally offered, opt-out HIV screening in the pediatric ED and use an innovative mHealth HIV pre-exposure prophylaxis (PrEP) navigation platform to identify and link at-risk youth to ongoing PrEP care. Results will contribute to the evidence base that informs the development of effective and sustainable HIV screening and prevention programs that can be successfully integrated into the clinical workflow of the ED.